Bone-Adipose Interactions During Skeletal Anabolism

Abstract
Bone formation by osteoblasts requires significant energy input to fuel the synthesis, deposition, and
mineralization of bone matrix. Fatty acids liberated by the lipolysis of triglycerides stored in adipose tissue are
a rich source of energy that is used to fuel the energy-intensive functions of a number of tissues. In this
application we will explore the interaction of bone and adipose tissue in response to two signals that stimulate
new bone formation: intermittent parathyroid hormone administration and exercise. Both of these stimuli are
also associated with increases in adipose tissue lipolysis. Our studies will determine the requirement for fatty
acids to be transferred from adipose to osteoblasts by examining bone formation in transgenic mouse models in
which lipolysis is impaired in adipocytes, via ablation of Atgl expression or fatty acid oxidation is impaired in
osteoblasts, via the ablation of Cpt2 expression. Our hypothesis predicts that manipulation of lipid metabolism
in either tissue will impair the bone formation response to each stimulus. Our approach will inform on the
integrative physiologic networks that regulate skeletal homeostasis and the energy substrates required for bone
formation during states of heighted anabolism. Additionally, these studies will enable us to define mechanisms
by which obesity and metabolic dysfunction, conditions which are now epidemic in our society, inhibit bone
formation

Public health relevance
Project Narrative This project investigates physiologic interactions between bone and adipose tissue during the response to two signals that stimulate new bone formation. Our hypothesis predicts that adipose tissue lipolysis induced by intermittent parathyroid hormone administration or exercise supplies fatty acids necessary to fuel bone formation by osteoblasts. Completion of this work may ultimately lead to the development of novel approaches for the treatment of both osteopenia and metabolic dysfunction.